Diurnal control of memory allocation by the circadian gene Per1

Project Summary/Abstract:
Humans and other animals are governed by an internal circadian clock that regulates the cycling of biological
processes, including memory, across the 24h day. Both non-pathological aging and Alzheimer’s disease are
accompanied by impairments in both memory and circadian rhythmicity, but the connection between these age-
related deficits is currently unclear. Recent work suggests that the circadian gene Period1 (Per1) may serve as
a molecular interface between the circadian clock and memory, as Per1 supports memory formation in the dorsal
hippocampus in addition to its well-documented role in the brain’s central clock, the suprachiasmatic nucleus.
Further, in old mice, hippocampal Per1 is abnormally repressed, contributing to age-related impairments in
spatial memory. Preliminary data indicates that Per1 is induced by learning during the day, when memory is
robust, but is not induced by learning at night, when memory is poor, suggesting that Per1 may modulate memory
formation across the 24h day. Additionally, Per1 regulates the activity of CREB, a transcription factor that is
critical for determining which individual neurons participate in encoding a given memory (a process termed
“memory allocation”). This proposal aims to understand how Per1 exerts circadian control over hippocampal
memory formation and determine how this process is changed in the old brain. Specifically, we hypothesize that
Per1 regulates the proportion of hippocampal neurons that express active CREB and are therefore allocated to
memory across the 24h day. Accordingly, reductions in Per1 that occur either at night or in old age may restrict
the number of cells allocated to memory, impairing memory formation. To fully test this hypothesis, we propose
three aims. In Aim 1, we will test whether Per1 controls circadian oscillations in hippocampal memory allocation
in young mice. Here, we will bidirectionally manipulate Per1 expression during the day and night with HSV-
CRISPR technology and use both behavior and Arc FISH-based neural ensemble monitoring to determine the
effects on both memory performance and memory allocation. In Aim 2, we will combine our bidirectional CRISPR-
based Per1 manipulations with viruses that either block (phospho-dead CREBS133A) or enhance (phospho-
mimetic CREBS133D) CREB phosphorylation to determine whether Per1 controls memory allocation by regulating
CREB activity. Finally, in Aim 3, we will first determine how circadian oscillations in both memory and memory
allocation change across the lifespan in 6-, 12-, 18-, and 24-m.o. mice. Then, we will test whether age-related
repression of Per1 disrupts CREB-mediated memory allocation, ultimately disrupting the circadian regulation of
memory in old mice. Together, our results will determine how the circadian clock interfaces with memory at a
molecular level and how disruption of this process contributes to age-related memory decline. These results
represent a significant conceptual advance in our understanding of age-related memory decline and may identify
potential targets for therapeutic intervention to improve cognition in old age.

Public health relevance
Project Narrative: Nearly all animals, including humans, are governed by an internal circadian clock that regulates biological processes, including memory formation, across the 24h day/night cycle. Both non-pathological aging and Alzheimer’s diseases are accompanied by impairments in both memory and circadian rhythmicity, but the connection between these age-related deficits is currently unclear. This proposal will examine an important circadian gene that may underlie age-related impairments in both memory and circadian rhythmicity and may represent a novel therapeutic target for improving cognition in aging individuals.